Early-life environmental exposure mixtures and biological age acceleration in children and adolescents: susceptibility, potential interactions and underlying mechanisms

PROJECT SUMMARY
Telomere attrition starts in early life, tracks into adulthood, and is associated with increased risk for aging-related
chronic diseases, such as cardiovascular disease. Because genetic factors explain only a small proportion of
telomere length variability, it is critical to determine prenatal environmental exposures that affect telomere length
dynamics in early life. Recent evidence shows that prenatal exposures to endocrine-disrupting chemicals (EDCs)
may promote telomere attrition in young children. However, existing data are limited, and the potential interplay
of EDC mixtures with other environmental stressors and the implicated mechanisms remain unknown. For
example, dietary factors and obesity also have been associated with shorter telomere length, potentially by
altering oxidative stress, inflammation, and metabolic pathways that are also disrupted by EDCs. Thus, EDC
exposures may act synergistically with diet and obesity to influence telomere length dynamics in childhood and
beyond. However, no previous study has examined the potential impacts and interactions of prenatal EDC
exposures with other factors on telomere lenght dynamics during the sensitive period of accelerated growth in
the transition from childhood to adolescence. Therefore, we propose the first and largest longitudinal
investigation on the prenatal exposome and telomere attrition, with extended follow-up through
adolescence. We will use an innovative multi-omics analytical framework to advance the knowledge about the
joint impacts of prenatal EDC exposures and their interplay with diet, obesity, and inflammatory and metabolic
pathways on telomere lenght dynamics and adolescent health. Our central hypothesis, supported by strong
preliminary results, is that prenatal exposures to EDC mixtures and their interactions promote telomere attrition
in childhood and through adolescence by dysregulating inflammatory and metabolism-regulating pathways. To
test this hypothesis, we will leverage the unique existing resources of the population-based Human Early Life
Exposome (HELIX) project. HELIX provides an unparalleled early-life exposome characterization (>200
environmental exposures) with completely harmonized biomonitoring data on ~80 known EDCs and repeated
telomere lenght measurements in 700 mothers and their children followed longitudinally from pregnancy to age
~16 years in six European countries. We will measure high-throughput proteomics covering >700 inflammation
and metabolic proteins in archived plasma from children collected at age ~8 years to comprehensively
characterize biological pathways promoting telomere attrition due to early-life EDC exposures, as well as their
interplay with telomere lenght tracking from childhood to adolescence. Findings will advance our understanding
of the impacts of early-life exposures to exogenous chemicals and their interplay with diet, obesity, and
inflammatory and metabolic pathways on telomere attrition during sensitive periods of development. This
knowledge will critically inform environmental public health policies and personalized interventions for early
prevention of cardiovascular disease as well as other highly prevalent aging-related chronic diseases.

Public health relevance
PROJECT NARRATIVE Biological age acceleration starts early in life, even at birth, and has been associated with increased risk for chronic diseases in later life. In this investigation, we will integrate data on environmental chemical exposures, lifestyle factors, and metabolic and inflammatory biomarkers, to determine the impacts of early life environmental exposures on biological age acceleration in children and adolescents, and implicated mechanisms. Findings may inform personalized interventions for the early prevention of aging-related chronic diseases such as cardiovascular disease.